Center for Research and Education on Aging and Technology Enhancement - CREATE

Project Summary
The landscape of aging and technology has changed dramatically. Uptake of technology is increasing among
aging adults; more researchers are focusing on this topic (many of whom are CREATE progeny); technology is
increasingly being considered as a solution for the support needs of aging adults; and more technology products
are marketed to seniors. These trends underscore the continued significance of the Center for Research and
Education on Aging and Technology Enhancement (CREATE). Deployment of technology in healthcare and
day-to-day activities is increasing and advances in technology such as artificial intelligence (AI) are increasingly
aimed at supporting older adults. Yet, aging adults are often ignored in design, and robust research evaluating
the usability, safety, and efficacy of these systems with older adults is limited. Even among older technology
adopters, rapid changes in technology pose challenges in terms of the constant need for adaptation and
continual learning. Further, there remains a lag in uptake among many older adult sub-groups, including ethnic
minorities, older cohorts, those of lower socio-economic status, those living in a rural location, or with a cognitive
impairment such as Mild Cognitive Impairment (MCI) or Alzheimer's Disease/Alzheimer's Disease Related
Dementias (AD/ADRD). This application is a request for continued support for CREATE, an established
multidisciplinary, cohesive, highly productive, and innovative Center that focuses on aging adults and technology
interactions. CREATE’s goal is to ensure that older adults are able to use and realize the benefits of technology.
CREATE V has a new vision, expanded research program and teams, and target populations, such as those
with MCI, expanded technical expertise, and access to an array of resources, community and clinical partners.
Given that age is a significant risk factor for cognitive impairments such as MCI and AD/ADRD, and the criticality
of cognition to everyday functioning, a thrust of our planned research is on using emerging technologies to help
maintain cognitive health and provide support for those with cognitive impairments. Our Research Program
includes three highly integrated cross-site projects focused on: 1) enhancing cognitive health and cognitive and
social engagement and preventing cognitive impairment; 2) providing support for adults with MCI and using
innovative techniques to assess further cognitive decline such as conversion to AD/ADRD; and 3) providing
cognitive support for health-management activities for those with and without cognitive impairments. Our cross-
site approach allows us to examine heterogeneity in response to our promising interventions. Our Program will
also include an expanded Pilot Research Program to support new research and investigators. CREATE will
involve three main sites: Weill Cornell Medicine, Florida State U. and the U. of Illinois Urbana-Champaign. J.
Sharit will remain as a Co-Leader (U. of Miami). We will also draw on faculty support from other campuses and
institutions. The Center will include Administrative, Data and Technical Development, and Dissemination Cores,
External Scientific and Community Advisory Boards, and an Industry Advisory Council.

Public health relevance
Narrative A pressing societal need is to ensure that the vast number of aging adults can maintain their independence and a good quality of life. Successful use of technology systems is critical to everyday functioning. Thus, examining issues surrounding aging and technology is important to the well-being and independence of older adults.